Exploiting SAMHD1 in Directing Radiation and Immunologic Dynamics

PROJECT SUMMARY
Immune checkpoint inhibition (ICI) has emerged as a promising approach for breast cancer; however, only about
10-20% of patients will respond due to lack of immunogenicity. Ionizing radiation (IR) damages DNA and
activates the immune system, potentiating ICI in breast cancer patients; however, overall response rates are
modest, highlighting the need for novel radiation combination strategies to potentiate ICI. SAMHD1 is recognized
for its dNTPase activity, which restricts HIV-1 infection and for mutations associated with Aicardi Goutières
syndrome. SAMHD1 is also overexpressed in up to 27% of breast cancers. We and others have shown that
SAMHD1 has a novel dNTPase-independent function in governing resistance to IR. SAMHD1 promotes DNA
end resection to facilitate DNA double-strand break (DSB) repair through the recruitment of CtIP to DSBs and
resection of nascent DNA at stalled replication forks by stimulating MRE11 exonuclease activity. The resection
function of SAMHD1 prevents the accumulation of cytosolic DNA that activates cGAS-STING to induce IFN-I
expression critical for maturation of dendritic cells and recruitment/stimulation of CD8+ T cells; however,
SAMHD1’s role in governing immunologic dynamics underlying anti-tumor immunity is not clear. Our preliminary
data indicate that SAMHD1 is highly expressed in triple-negative breast cancer (TNBC) and high SAMHD1
expression is associated with decreased IFN-I signaling, decreased CD8+ T cell tumor infiltration, and poor
survival. We have also identified a novel immune niche in TNBC consisting of antigen presenting cells (APC)
closely associated with progenitor CD8+ T cells. Progenitor CD8+ T cell differentiation into tumor lytic terminally
differentiated effector-like cells (TD) is essential for a robust αPD-1/L1 response. Finally, we developed a novel
strategy for the in vivo degradation of SAMHD1 whereby SAMHD1 is targeted with Vpx, a lentivirus accessory
protein, packaged in virus-like particles (VLP). We hypothesize that SAMHD1 governs the resistance of breast
cancer to IR and ICI at least in part through a dNTPase-independent function in suppressing cytosolic DNA and
activation of the innate immune response that potentiates ICI by stimulating progenitor CD8+ T-cells. Targeting
SAMHD1 for degradation with VLPs with Vpx sensitizes resistant breast cancer to IR and ICI. We propose to: 1)
Determine the molecular mechanism by which SAMHD1 directs radiation and immunologic dynamics underlying
response to ICI, 2) Determine the mechanism by which SAMHD1 directs radiation and immunologic dynamics
in TNBC patients, 3) Determine if targeting SAMHD1 with VLPs with Vpx sensitizes TNBC tumors to IR and ICI.
Completion of this work will define the mechanism by which SAMHD1 directs radiation and immunologic
dynamics underlying anti-tumor immunity in breast cancer via stimulation of progenitor CD8+ T cells. This work
will also elucidate the significance of SAMHD1 as a potential rationale-driven biomarker for selecting breast
cancer patients who may benefit from IR and ICI. Finally, this work will establish proof of concept for the use of
VLPs with Vpx in targeting SAMHD1 as a novel approach for overcoming breast cancer resistance to IR and ICI.

Public health relevance
PROJECT NARRATIVE Completion of this research will provide a detailed mechanistic understanding of how SAMHD1 directs radiation and immunologic dynamics underlying anti-tumor immunity in breast cancer via stimulation of progenitor CD8+ T cells within a novel immunologic niche. As SAMHD1 is often overexpressed in breast cancer, particularly in TNBC, this work will also elucidate the significance of SAMHD1 as a potential rationale-driven biomarker for selecting breast cancer patients who may benefit from IR and ICI. Finally, this work will establish proof of concept for the use of VLPs containing Vpx in targeting SAMHD1, exploiting how viruses naturally target SAMHD1 for degradation, as a novel radiation combination approach for overcoming breast cancer resistance to IR and ICI that may significantly improve clinical outcomes for patients with breast cancer.